NITRIC OXIDE REGULATION OF RENAL OXYGENATION DURING SEPSIS

We are now practised in the complex surgery of isolating and perfusing kidney from a rat. Oxygen-sensitive crystals of LiPc were placed in the cortex and outermedulla so as to measure the partial pressure of oxygen (pO2) simultaneousl y in both these regions within the same kidney, allowing us to compare these results with our in vivo model. The advantages of using a perfused system are that many parameters can be measured and tightly controlled: 1) The dependence of tissue pO2 on perfusion pressure and/or flow rate in the control kidney, the pO2 in the cortex region is high compared to that in the medulla. However, at a critical pressure, the pO2 in the medulla sharply increases to a level equal to that in the cortex. If the pressure was again increased, we found that this phenomenon was reversed. 2) The effects of nitric oxide on oxygenation- by addition of nitroprusside (a nitric oxide donor) or a blocker of nitric ox ide synthesis, we were able to control the vasodilation of vessels in the medulla, and monitor the effects on pO2. 3) Endotoxin (either by bolus dose or continuous infusion) probably induces NO synthesis in the medulla, since we observed an increase in tissue pO2 with little change in tissue oxygen consumption.